Fracture Repair in Aging: Identifying networks by miRNA and mRNA co-sequencing

There is an urgent clinical need to develop new bone regenerative therapeutics to treat delayed and non-union
fractures, and critical sized bone defects. Moreover, aging results in severely impaired skeletal repair. A critical
aspect of fracture healing begins with expansion of periosteal progenitors, which are activated immediately
after injury and then differentiate into bone forming osteoblasts and chondrocytes. However, the molecular
mechanisms controlling their activation, expansion, and differentiation in response to injury remains limited.
microRNA (miRNA) mediated post-transcriptional regulation of gene expression plays a key role in the
commitment and differentiation of stem cells toward the osteoblastic or chondrogenic lineages. Since a single
miRNA can potentially target hundreds of distinct mRNAs, identifying the gene expression networks controlled
by miRNAs continues to represent a significant gap in our understanding of skeletal biology and repair.
Differences in miRNA expression can be observed between young and old bone, and likely mediate some of
the impact of aging on fracture repair.
Non-biased whole transcriptome analyses have revealed important information about gene expression
programs active in the resting periosteum and in healing fractures. Studies utilizing RNA extracted from whole
bone have documented changes in either mRNA or miRNAs in these tissues. However, single cell RNA
sequencing studies readily demonstrate the cellular heterogeneity present in periosteum and in regenerating
bone, making less clear the interpretation of bulk RNAseq studies in these complex tissues. The ability to
observe coordinated mRNA-miRNA networks in individual cells during fracture repair will provide paradigm-
shifting information that could be used to enhance repair. Further, local delivery of miRNA-based therapeutics
represents an exciting novel strategy for facilitating bone healing in the elderly. A thorough understanding of
the mRNA-miRNA networks active in each cell type in the healing bone will provide critical rationale for
miRNAs to target in a therapeutic setting.
We propose to perform single cell mRNA-miRNA co-sequencing on non-hematopoietic lineage cells isolated
from resting periosteum and periosteum activated by fracture, comparing young and aged mice. This will allow
us to identify expression-based cell subpopulations and mRNA-miRNA interaction networks within those
populations, and how these are modulated during fracture repair and in aging. Protocols for single cell miRNA-
mRNA co-sequencing were only recently developed. The complex micro-environment of fracture repair is an
ideal application for this new technology, which will fill a significant void in our understanding of skeletal biology
and provide a rationale for further investigation of miRNA-based therapeutics for bone repair.

Public health relevance
An understanding of the cellular and molecular mechanisms underlying fracture repair in the young, and how these mechanisms are altered in aging, is the key to developing new therapeutics to facilitate bone healing in the elderly. Periosteal cells, residing on the outside of the bone, are a heterogenous population that plays a critical role in fracture repair. This project will utilize state of the art techniques to compare the subpopulations of cells and regulatory pathways active in periosteal bone repair in young and old mice, which will help to identify novel targets for therapeutic intervention.